Influenza Forecasting Center of Excellence at University of Massachusetts Amherst

PROJECT SUMMARY/ABSTRACT
The central goal of this project is to serve as a strong, interdisciplinary center of forecasting research
and science. We will achieve this through innovation in development of forecasting methodologies
and systematic research into optimal the communication and visualization of forecasts. By working
with the US Centers for Disease Control and Prevention in this cooperative agreement, we aim to
extend existing methodologies to incorporate new data sources and model structures, thereby
improving influenza forecast accuracy in the US.
We will review and revise existing FluSight forecasting guidance, targets, and accuracy evaluation at
the national, regional, and state levels. This will include conducting stakeholder interviews with
federal, state, and local epidemiologists to track uses of forecasts and outcomes and identifying
unmet needs from current forecasts. We will develop and refine methods to create forecast
ensembles, with a specific focus on developing ensemble weighting schemes using robust, penalized
methods to estimate model weights. We will identify methodologies and data sources that increase
forecast accuracy for start and peak week forecasts, peak intensity, and short-term forecasts at the
national, regional, and state level. Our work here will focus on developing multi-scale spatial models
that leverage state and zip-code level data on influenza infections from public and private sources.
We will develop communication products and methods to describe forecast results and uncertainty for
federal and state public health officials and the public. We will achieve this by incorporating new
visualizations into our existing interactive data visualization product for influenza forecasts in the US
and studying systematically the end-user perception of various visualization and data presentation
layouts. Finally, we will develop and adapt successful seasonal methodologies, data sources, and
communication approaches for forecasting the timing, intensity, and short-term trajectory of an
emerging influenza pandemic. Specifically, we will create, test, and disseminate weekly data
summaries and visualizations from the most up-to-date sources of reported influenza cases in the US
(including data from our real-time point-of-care data sources), and validate our new spatial models
against simulated pandemic data.

Public health relevance
PUBLIC HEALTH NARRATIVE Real-time forecasts of future incidence of infectious disease can be used to help mitigate the impact of ongoing epidemics. The fusion of public health surveillance data, clinical data generated at the point-of-care and cutting-edge statistical methodologies can improve the accuracy and public health relevance of forecasts. The goal of this center is to support ongoing real-time influenza forecasting efforts in the United States through innovation in development of ensemble and stand-alone forecasting models and systematic research into communication and visualization of forecasts.